HYPERLIPIDEMIC EFECTS OF BAYW6228 OR LOVASTATIN IN HYPERCHOLESTEROLEMIC ADULTS

This study will evaluate the hypocholesterolemic effects and influence on cholesterol biosynthesis of the most potent inhibitor of cholesterol biosynthesis, BAYw6228, at doses of 50, 100, 200 and 300 ug/day in patients with primary hypercholesterolemia. As a control group one out of six patients will receive lovastatin (40 mg/day) and one out of six patients will receive placebo. Up to 30 patients will be involved in the study which will last for a total of 34 weeks.